Whole genome sequencing based tracking of pathogens in Animal Diagnostic Specimens

Abstract
The goal of this proposal is to enable the Animal Disease Research Laboratory(ADRDL),
South Dakota to serve as a whole genome sequencing laboratory for CVM Vet-LIRN
Veterinary Diagnostic Laboratory Program. ADRDL is one of the nationally preeminent
full service, animal disease research and diagnostic laboratories that provides the fastest,
most accurate, and most dependable animal disease diagnostic services possible.
ADRDL is a not-for-profit lab and provides state-of-the-art diagnostic services and
instrumentation for the detection of zoonotic and animal diseases and conducts over 500,
000 diagnostic tests every year. In this project, ADRDL will receive isolates from other
source labs in Vet-LIRN network, sequence genomes of those isolates, perform
bioinformatics analysis of the data and submit the raw data and results to Vet-LIRN
program office and NCBI sequence read archive.

Public health relevance
Project Narrative The pet and animal industry is a major contributor of the United States economy. However, many outbreaks of food borne and zoonotic pathogens originate from pets and agriculturally important animals. Veterinary diagnostic laboratories detect and report diseases from pets and animals and ensure that zoonotic diseases do not cause outbreaks in humans. In the proposed cooperative agreement, Animal Disease Research and Diagnostic Laboratory (ADRDL), South Dakota seeks to serve as a whole genome sequencing laboratory, sequence and analyze pathogen genomes for the Food and Drug Administration (FDA), Center for Veterinary Medicine (CVM) Office of Research Veterinary Laboratory Investigation and Response Network (Vet-LIRN).